Understanding immigrants' cardiovascular disease utilization: An epidemiological and system dynamics approach

PROJECT SUMMARY
Cardiovascular disease (CVD) is one of the leading causes of mortality in the U.S. When immigrants first arrive in the U.S., they have better CVD risk factor profiles than the U.S.-born, but within 5 to 15 years of living in the U.S., they experience a worsening of their CVD risk factor profiles. Some immigrants have lower screening, monitoring, and treatment of CVD risk factors than U.S.-born populations. Lower preventive care utilization likely contributes to their worsening cardiovascular health. Eliminating differences in CVD preventive care utilization is necessary to improve the cardiovascular health trajectory of immigrants and lessen the burden of CVD mortality in the U.S. The research objective of this career development award is to use epidemiologic, system dynamics, and community-engaged methods to understand how individual and multiple components of the environment (e.g., language barriers, provider accessibility, policies and practices, sentiment) affect immigrants’ CVD preventive care utilization. This research will also address current gaps in research by focusing on CVD preventive care utilization outcomes and using objectively measured, longitudinal electronic health record data (EHR). The research objective will be achieved through three novel aims. Aim 1 is to estimate trends and associations between state and county-level policies and practices, hate crime rates, and CVD preventive care utilization among immigrant adults using electronic health record data from a nationwide network of community health centers. Aim 2 is to develop a system map with community stakeholders that graphically depicts hypothesized causal relationships and feedback loops within the environment that affect immigrants’ CVD preventive care utilization. Aim 3 is to develop a system dynamics simulation model to estimate improvements in CVD preventive care utilization as different components of the environment are manipulated. This multidisciplinary research plan directly addresses NHLBI’s critical challenge to advance methods of assessing and characterizing exposures to understand differences in health among populations. The research aims are complemented with a training plan that builds upon the candidate’s expertise as social epidemiologist to develop the candidate’s expertise in the (1) measurement and quantification of components of the environment, (2) analysis of longitudinal EHR data, (3) use of system dynamics simulation methods, and (4) use of community-engaged research and community-based system dynamics methods. Together, the research and training plans will prepare the candidate to become an interdisciplinary, independent research investigator whose career is aimed at improving the cardiovascular health trajectories of immigrants in the U.S.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is one of the leading causes of mortality in the U.S. and lowering the burden of CVD through prevention and treatment is important to public health. Some immigrants have lower awareness, screening, monitoring, and treatment of CVD risk factors than U.S.-born populations, which may contribute to the observed decline in their cardiovascular health over longer residence in the U.S. This project will use epidemiologic, system dynamics, and community-engaged methods to understand and quantify how different facets of the environment affect immigrants’ CVD preventive care utilization.